Flow Cytometry & Cell Sorting Shared Resource

FLOW CYTOMETRY & CELL SORTING (FCCS) SHARED RESOURCE: SUMMARY
The mission of the Flow Cytometry & Cell Sorting (FCCS) Shared Resource is to provide the Hollings Cancer
Center (HCC) research community with an integrated platform to sort and analyze cells and evaluate pre-
clinical and clinical experimental data in a cell-specific manner. Under the leadership of Amanda C. LaRue,
PhD (CBI), FCCS offers comprehensive high-speed cell sorting services, high-dimensional single-cell
analyses, the development of new methodologies, and an educational platform to further basic and
translational research. Flow cytometric techniques allow for rapid phenotypic and functional analysis of
biological processes and isolation of single cells, methodologies that are critical for detailed analyses of cell
types contributing to the complex processes of cancer initiation, metastasis, and progression. Immune
monitoring services evaluate patients' immune responses and provide valuable data needed for preclinical and
basic laboratory investigations in animals or tissue culture. These methodologies have provided essential
insights into how cancer evolves, opening new opportunities for therapeutic interventions. This is accomplished
by providing assisted and unassisted flow cytometry analysis, consultation on experimental design, sample
preparation, data analysis, and preparation, along with hands-on training in flow cytometric technology and
analytical equipment. Due to substantive new equipment acquisition, multi-parametric, high-dimensional
analyses have expanded during this cycle. FCCS added a Hyperion to the CyTOF System for imaging mass
cytometry that allows antibody-based detection and analysis of up to 135 simultaneous targets. FCCS also
added a Beckman Coulter CytoFLEX LX and a Cytek Northern Lights, both high-dimensional “next-generation”
analyzers. The primary sorter, a BD FACSAria II, has also been upgraded to a BD FACSAria III. To meet the
educational mission of FCCS, a formal, comprehensive training program, Ready, Set, Flow, was developed
during the last review period. During the current cycle, FCCS was utilized by 70 HCC members and provided
key data and insights to support the success of 112 peer-reviewed publications, including work published in
high-impact journals such as Nature Med, JCI, Cell Reports, Cell Mol Immunol, Cancer Res, Cancer Immunol,
and JBC. In summary, FCCS advances, supports, and provides critical, cutting-edge research tools and
methodologies to the HCC community.